IDENTIFICATION OF NEUTRALIZING EPITOPES ON PERTUSSIS TOXIN

The laboratory continues to provide investigators in many research laboratories within and oustide of the FDA with monoclonal antibodies (mABs) generated against pertussis toxin(PT). These mABs have been useful in research directed towards identification of epitopes within the PT molecule, which are a significant factor in acellular vaccine design.